Improving Outcomes in Depression in Primary Care

Project Summary Abstract
Depression is the leading mental health related contributor to the Global Burden of Disease. We have shown in
previous studies that generic antidepressant medications (ADMs) and brief psychological interventions such as
our culturally adapted version of behavioral activation, the Healthy Activity Program (HAP), are effective in
achieving remission in primary care patients. However, not everyone responds to either intervention and
similar aggregate outcomes can mask considerable individual variability in response. The goal of our proposed
research is to see if we can enhance treatment outcomes for patients with moderate to severe depression by
personalizing allocation to one of the two treatments; additionally, we aim to identify those patients who are
unlikely to respond to either treatment and should be referred to specialist care. To achieve this, we will use
machine learning to develop a precision treatment rule (PTR) based on a wide range of baseline moderators
which are feasible to assess in routine care settings. Our primary hypothesis is that those patients randomized
by chance to their optimal intervention as indicated by the PTR will be more likely to remit and recover than
those who are not. Moreover, we hypothesize that using our PTR to select the optimal treatment for each
individual patient will prove to be more cost-effective than leaving things to chance. We also plan to explore
secondary questions, such as whether we can enhance our mediation tests by including the PTR in
interactions with our purported mediators (moderated mediation). Further, we plan to explore whether we can
enhance the prescriptive utility of our PTR via genotyping our sample and calculating polygenic risk scores
based on very large sample Genome-Wide Association studies. We will test these hypotheses in a controlled
trial in primary care settings in India where we have a record of conducting depression treatment trials for two
decades. We plan to randomize 1500 individuals to either HAP or ADM and generate our PTR on the first 1000
patients randomized and then test it on the remaining 500 patients. This will be the first test of whether
precision medicine can be used to enhance depression treatment outcomes through prediction of differential
response to the two treatments recommended by the WHO for depression in primary care. Concurrently, we
also should be able to identify baseline predictors of nonresponse to either of these two treatments, so as to
identify patients who should be referred to specialist care at the outset. Our findings have the potential to make
significant contributions to the prospect of optimizing the treatment of depression in primary care not just in
India but also in primary care settings worldwide, and thus support the practice-related goals of NIMH RFA-
MH-18-701.

Public health relevance
Project Narrative OptimizeD trial will generate a PTR to determine which of the two most widely used treatments in primary care, antidepressant medication or brief psychological treatment, are most effective for an individual patient, supporting a more personalized approach to depression care. Conducting the study in India enables recruitment of a large and diverse sample, improving the robustness and generalizability of the treatment algorithms across varied demographic and socioeconomic populations. Because the diagnostic criteria, treatment approaches, and candidate predictors are well-established in the United States, the findings are expected to directly inform U.S. depression care by improving treatment matching, reducing trial-and-error prescribing, and enhancing the efficiency and cost-effectiveness of mental health care delivery.